Probing the role of SORL1 and endosomal network genetic variation on Alzheimer's disease phenotypes in human neurons.

Project Summary/Abstract
The purpose of this study is to determine whether genetic variants associated with AD risk in the SORL1 gene
and other endocytic genes lead to endosomal network dysfunction and cellular AD phenotypes in human
neurons. Endosomal abnormalities are documented in post-mortem AD brain tissue and multiple endocytic
regulatory genes are associated with increased AD risk in population studies. SORL1 is a vesicular trafficking
gene that functions in transporting cargo between endosomes, Golgi and the plasma membrane. SORL1 plays
an integral in trafficking amyloid beta and the amyloid precursor protein through the endocytic network and loss
of SORL1 is documented in AD brain tissue, possibly contributing to senile plaque formation. This pathway
represents a novel avenue for therapeutic development in AD. Our previous studies have used human induced
pluripotent stem cell (hiPSC)-derived neurons (hiPSC-Ns) to show that deficiencies in SORL1 expression
induction are correlated with the presence of AD-associated variants in non-coding regions of SORL1. In this
work, we hypothesize that risk variants in endosomal network genes predicts cellular endocytic and AD relevant
phenotypes. To test this hypothesis, we will leverage our long-standing expertise in hiPSC-derived neuronal
differentiations with our newly developed methods to generate hiPSC-neurons and directly transdifferentiated
neurons from post-mortem AD tissue to test i) whether AD associated variants lead to loss of function of SORL1
resulting in endosomal and AD-relevant phenotypes; ii) whether cellular age exacerbates these phenotypes; and
iii) whether a cumulative burden of AD risk variants in the endocytic pathway predicts endocytic phenotypes. We
have identified AD patients with SORL1 coding variants and have obtained fibroblasts from these patients for
hiPSC-generation. We will use CRISPR/Cas9 gene editing to correct the variants in patient cells and introduce
the variants in control cells, generating an allelic series of cell lines that will include one or two copies of the
variant allele as well as SORL1 knock-out cell lines. We will differentiate neurons from these lines and assay
defined phenotypes of endosomal and AD pathology: Enlarged endosome size, decreased endocytic recycling,
increased A peptide secretion and increased Tau phosphorylation. Furthermore, we will generate induced
neurons (iNs) from patient and control fibroblasts by direct conversion to test whether endocytic phenotypes are
enhanced when cellular age is maintained. Finally, we will derive hiPSC-Ns and iNs from cases with autopsy
confirmed AD and high risk burdens of AD-associated SNPs in endocytic genes. We will perform our endosomal
assays and generate phenotypic groups. This work is significant in that it will investigate a functional genotype-
phenotype relationship of genetic variants in the endosomal network, which is known to be disrupted early in AD
pathogenesis. Investigating this driver of disease pathogenesis and how it relates to human genetic background
is critical in the development of new and precision treatments for AD.

Public health relevance
Project Narrative Alzheimer’s disease (AD)is a devastating neurodegenerative disorder that has no cure. Genetic studies and neuropathology implicate vesicular trafficking pathways in cells to be disrupted in AD prior to amyloid beta or tau changes. Through dissecting these pathways in human stem cell-derived neurons, we will advance the goals of identifying candidate therapeutic targets.